Unraveling the Role of PD-1 in CD8+ Tissue-Resident Memory T Cell Homeostasis and Epithelial Damage in Human Colitis

Project Summary
Monoclonal antibodies against co-inhibitory immune receptors PD-1 and CTLA-4 [immune checkpoint inhibitors
(ICIs)] have revolutionized immuno-oncology by reversing T cell exhaustion and harnessing the power of the
immune system to fight solid tumors. Although ICI therapy has improved the survival of patients with metastatic
cancer, treatments are unfortunately limited by the development of immune-related adverse events. Colitis is
the most common, severe side effect of ICIs – seen in 5-10% of patients on PD-1 and up to 50% of patients on
dual PD-1/CTLA-4 blockade – and is marked by epithelial injury and apoptosis. To date, little is understood
about the immunologic underpinnings of PD-1 colitis, in part because mice treated with PD-1-blocking
antibodies do not readily develop gastrointestinal toxicities. This proposal presents a five-year research career
development program focused on understanding the immune drivers of human colitis that develops after PD-1
blockade [i.e., immunotherapy-related colitis (irColitis)]. Dr. Molly Thomas is an Instructor of Medicine at
Harvard Medical School in the Division of Gastroenterology at Massachusetts General Hospital. This award will
provide Dr. Thomas with the support necessary to test the hypothesis that irColitis is caused by the expansion
of specific colon CD8+ T-resident memory (Trm) cells into cytotoxic effectors that produce IL-26 and IL-17A
and home directly to damaged epithelium where they have deleterious effects on epithelial turnover and
absorptive function. This hypothesis will be tested through the following aims: (Aim 1) Define the epigenetic
landscapes and effector functions of distinct colonic CD8+ Trm and Trm-derived effectors; (Aim 2) Determine if
CD8+ T effectors detected in the colon mucosa of irColitis patients circulate in blood and which blood immune
cell states track with disease; (Aim 3) Map interactions between CD8+ Trms and damaged epithelial cells to
understand how PD-1 inhibition leads to interferon-dependent defects in CD8+ Trm homing and epithelial
absorptive function. Through these proposed aims, Dr. Thomas will map the complex interactions between
CD8+ Trms and damaged colonic epithelium following PD-1 blockade. She will work under the guidance of her
primary mentor Dr. Nir Hacohen, an expert in immuno-oncology and autoimmunity, and her co-mentor Dr.
Alexandra-Chloé Villani, an expert in leveraging single cell genomics to understand immune heterogeneity in
health and disease. The proposed experiments, analyses, and didactic work will provide Dr. Thomas with a
unique set of skills that will enable her to transition to independence as a physician-scientist studying immune-
mediated gastrointestinal diseases. These studies will define mechanisms by which IL-26+ and IL-17A+ CD8+ T
cell effectors orchestrate pathologic inflammation and will allow for the development of diagnostic tools and
treatment strategies that will be broadly applicable to irColitis patients and those with inflammatory bowel
disease. By year four of this five-year award, Dr. Thomas will be well-positioned to develop an R01 application
to define pathologic Trm responses in the human gastrointestinal tract and therapeutic targets to treat irColitis.

Public health relevance
Project Narrative PD-1 inhibitors are increasingly used for the treatment of solid tumors yet their clinical utility is limited by the development of immune-related adverse events, of which colitis is the most common, severe side effect. The goal of this project is to use a combination of single cell genomic and T cell receptor sequencing in combination with multiplexed immunofluorescence microscopy and organoid culture to characterize the interactions between damaged colonic epithelium and cytotoxic T lymphocytes, which sustain tissue inflammation following PD-1 blockade. These findings are directly relevant to public health because they will increase our understanding of how PD-1 signaling promotes immune tolerance in the gut and will identify new strategies to diagnose, treat, and prevent PD-1 colitis and other gastrointestinal immune-mediated diseases.